A mobile health framework for left ventricular end diastolic pressure diagnostics and monitoring.

PROJECT SUMMARY/ABSTRACT
This SBIR Fast-Track project will develop a novel mobile health framework for left ventricular end diastolic
pressure diagnostics and monitoring, using an innovative, non-invasive cardiac biosensor. Heart disease is the
leading cause of death for men and women accounting for more than one-third (33.6%) of all U.S. deaths. The
total costs associated with cardiovascular disease in the U.S. were estimated to be $363 billion, making it the
costliest health problem facing the nation. In addition, it occurs disproportionately among minority and health
disparity populations. For example, heart failure related deaths are 30% higher among African-Americans than
among non-Hispanic whites. Left ventricular end diastolic pressure (LVEDP) is a reflection of ventricular
compliance and intravascular volume and pressure; it relates both acutely and chronically to clinical conditions
that affect ventricular performance. LVEDP is elevated in the setting of heart failure (HF), and its measurement
is used in the management of HF. Overall cardiac health can be significantly improved by proper triage at the
primary care level by determination of the LVEDP without requiring a 2-D echo-cardiogram or left heart
catherization. It will provide health care professionals with technology to guide diagnostic and facilitate easy
home-based management by patients. Using everyday smartphones makes it even more accessible and
readily available without adding high costs. As the technology being developed does not require skilled
operators or specially trained physicians, it will allow healthcare providers to assess LVEDP within their normal
medical training. Through the course of this project we will validate this revolutionary mobile health framework
that enables measurement of LVEDP using everyday smartphones. The scope of the science proposed in this
project is to complete development of the diagnostic framework using our specially engineered sensor system
combined with the novel algorithm technology to be accessed via a smartphone for a portable and cost-
effective solution. Resource-poor communities across the globe lack access to quality healthcare arising from
shortages in medical expertise and poor availability of expensive medical diagnostic devices. In recent years,
mobile phones have become increasingly advanced and ubiquitous. The mobile framework developed through
this project is a tremendous opportunity to provide low-cost diagnostics to under-served populations. The
benefit of this pioneering work is the development of an easy-to-use solution that can measure ventricular
compliance, and thus enable improved screening during routine annual checkups, doctor visits, at community
medical screenings, classes, and health fairs leading to healthier communities. It will make measuring LVEDP
as routine as measuring blood pressure. In Phase II, we will continue validation of the device through user-
trials and seek FDA 510(k) clearance for commercialization. Followed by commercialization in the Florida and
nationwide, based on the partnerships and joint collaborations established to help create a commercially
successful product.

Public health relevance
PROJECT NARRATIVE Overall this project provides direct relevance to public health by facilitating new insights through the development of a novel mobile framework to be used in current clinical practice for non-invasive direct assessment of the left ventricular end diastolic pressure. The novel biologically-inspired device will significantly impact the current known methods for detection, monitoring, prevention and treatment of heart failure, and support evidence-based clinical practice. The project will help reduce health disparities in the area of heart disease, assist in providing preventive cardiac care, assist in improving access to care, assist in early diagnosis of the risk of heart diseases and it will significantly impact the current known methods, technologies, treatments, and address critical barriers to progress in the field.